A South Carolina ECHO Pregnancy Cohort

ABSTRACT
Animal and epidemiological studies show that prenatal experiences (e.g., elevated environmental pollutants,
pregnancy complications, preterm birth, stress, racial discrimination) support the ‘developmental origins of
health and disease’ model in relating adverse maternal experiences to compromised fetal and child
development. Hypotheses suggest that the developmental window of plasticity for obesity programming
initiates in utero and extends through the first two years of life, underscoring the large impact that gestational
and early life exposures and corresponding targeted interventions may have on lifetime obesity risk. Current
obesity interventions may be ineffective because they target children or adults past the critical age when
developmental programming occurs. Because vulnerable populations are often the most impacted by exposure
to environmental stressors and poor health outcomes, it is critical that research studies include them.
Therefore, the overarching objective of our proposal is to increase the diversity of the ECHO Cohort. To
achieve this goal, we will recruit over 500 pregnant persons and their resulting offspring into ECHO from the
Medical University of South Carolina (MUSC) and implement the ECHO-wide protocol including specialized
components on Physical & Chemical exposures and child Obesity outcomes. Our proposed recruitment will
include 50% Black, 30% white/other and 20% Hispanic pregnant persons with half of the pregnant persons
(and their conceiving partners) also contributing to the preconception cohort. The racial and ethnic diversity of
the MUSC obstetrical population (i.e., 32% Black; 53% white; 12% Hispanic; and 2% Asian/Pacific Islander),
and large delivery population (i.e., over 3,000 annually) will facilitate meeting our recruitment goals. In 2022,
46% of deliveries at MUSC were covered by Medicaid and 5.5% were to Spanish speaking mothers, providing
further evidence of high social vulnerability in our study population. Because previous research has often been
conducted in urban areas, rural communities where many Blacks reside are often understudied. Hence, as a
rural state in the Deep South with poor birth outcomes and a socially vulnerable population, South Carolina’s
population is historically understudied and our contribution to ECHO will have a major impact. Our aims
pertaining to ECHO-wide analyses are (1) to determine the joint impact of prenatal exposure to chemical
mixtures and early gestational and life exposures (i.e., hypertensive disorders of pregnancy, preterm birth) on
child obesity and metabolic health; (2) to identify racial/ethnic disparities in prenatal chemical exposures and
their sources (dietary choices/opportunities, use of consumer goods and personal care products, occupation,
air/water) among participants in the ECHO cohort; and (3) to determine the association of mixtures of pre-
conceptual and peri-conceptual chemical exposures measured in both partners with hypertensive disorders of
pregnancy, preterm birth, and child obesity.

Public health relevance
NARRATIVE An ECHO Pregnancy Cohort site in Charleston, South Carolina, will fill an important recruitment gap by enrolling a study population from South Carolina. Pregnancy and preconception studies of environmental exposures that extend through childhood are critically needed to understand gestational and early life exposures and their association with health and disease in children and adults. Our proposed aims are innovative because they address the impact of joint exposure to chemical and non-chemical stressors, potential rural-urban differences in sources of chemical exposure and resulting complex chemical mixtures, and the identification of critical windows of exposure to complex chemical mixtures.